DEVELOPMENTAL BIOLOGY PROGRAM

The central theme of the Developmental Biology (DB) Program is that cancer is often the result of corrupted developmental regulatory networks. We strive to use the powerful molecular genetics available in model organisms to understand fundamental signaling processes underlying normal development, and the abnormalities in these pathways that can lead to cancer. The goal is to provide key new targets for chemopreventive and chemotherapeutic interventions. Program Membership: Since the last renewal, the Developmental Biology Program has undergone several leadership changes. Dr. Bryant stepped down as the program leader to focus on rejuvenating the Graduate Program in Molecular Biology Genetics and Biochemistry and was replaced by Dr. Blumberg. After his stint as Graduate director ended, Dr. Bryant rejoined the program as Co-Leader in 2006 and was replaced by Dr. Marsh in 2007. Drs. Bode and Fallon retired and Dr. Brachmann transitioned to Associate Member. New Members include Dr. Maike Sander who moved from GF, and Drs. Peter Donovan, Taosheng Huang, Tom Schilling, and Rahul Warrior who joined the Program. The DB Program has 16 Members, representing five Departments and two Schools, and has $5,019,083 in direct cancer-related peer-reviewed funding, 1 project of which is funded by NCI for a direct total of $152,000. In 2007, Members published a total of 28 publications with 18 of those being cancer-related of which 22% were inter- and 6% were intra-related.